Effect of Constraint-Induced Gaming Therapy in an Acute Care Setting

More than 6000 Veterans each year have an ischemic stroke that often results in some level of hemiplegia. Poor outcomes in stroke therapy leave the Veteran less able to participate in follow- up therapy post-discharge, reduces ability to complete activities of daily living, and contributes to an average cost of care three times the typical Veteran. Current protocols for therapy on a rehabilitation unit call for intensive rehabilitation composed of high intensity, long duration therapy. Evidence from brain healing and animal research, along with motor learning principles suggest that a treatment program composed of short duration therapy sessions distributed throughout the day may provide better rehabilitation outcomes for stroke patients. Such a program can be implemented using constraint-induced therapy in which the Veteran is provided with opportunities to use the affected limb while participating in a video game and completing complementary tasks in therapy. Additionally, rehabilitation outcomes may improve if Veterans are provided with regular opportunities to participate in gaming therapy at home after discharge from the hospital rather than having to travel to a clinic or receive limited or no follow-up in rural areas. This project will develop a therapeutic model for applying constraint-induced therapy via a video gaming environment that has movements paired with motor retraining performed in therapy sessions. A small group of patients will participate in a question and answer session about preferences for activities which make up transfer tasks. Transfer tasks are paired with movement performed while playing the video game. Patients will also receive automated reminders to use the impaired arm throughout the day. Ten Veterans will be recruited annually from the inpatient Stroke Specialty Program. Five patients will be assigned to the Treatment group and receive the intervention. The remaining five will receive the current standard of care. Outcome measures will include motor function tests that evaluate upper extremity function. Preliminary results will be presented at a major conference with project results submitted to a relevant peer-reviewed journal. Norms from this project will serve as the basis for a larger, multi-site Merit grant proposal. We believe this project will lead to substantive change in the treatment of acute stroke that will lead to improved functional outcomes for Veterans and reduced care costs for the VA.

Public health relevance
Veterans in the hospital recovering from a stroke typically do at least 3-4 hours of therapy each day. However, current research into how the brain heals favors less intense practice. Other obstacles to recovery after the Veteran leaves the hospital are finding transportation to therapy appointments and finding a clinic in rural places. When recovery from stroke is not good, Veterans are more disabled, don't enjoy life as much and the VA pays about three times more for medical care. This project will use a form of rehabilitation therapy called “constraint-induced” therapy using a video game system. This therapy encourages increased use of the affected arm and is facilitated by work with an Occupational Therapist. It includes a “transfer package” that translates therapy activities to activities of daily living. Veterans will keep doing therapy at home using the video game system. This project will develop a treatment using constraint-induced gaming to improve quality of life for Veterans who experience stroke and to reduce overall cost of care to the VA.